Exploring the function and shedding of a potential C. elegans Neuregulin

PROJECT SUMMARY/ABSTRACT
Signaling by Epidermal Growth Factor (EGF) family ligands through EGFR/ErbB receptors controls
myriad developmental and behavioral processes across metazoa and its dysregulation contributes to
human diseases such as cancer and schizophrenia. Our understanding of EGF signaling is founded in
studies of the nematode C. elegans, which for decades has served as a model for the function of a
single ligand–receptor pair, encoded by lin-3/EGF and let-23/EGFR. The central role for EGF signaling
in C. elegans vulval organogenesis, along with the powerful molecular-genetic tools available in this
model system, has revealed foundational concepts in signal transduction. In recent years an EGFR-
dependent sleep state triggered by various forms of cellular damage has been identified in C. elegans.
This stress-induced sleep (SIS) has since been observed in Drosophila and zebrafish, and may
represent a core constituent of sleep drive. Consistent with this notion, EGF family ligands have been
found to have sleep-promoting activity across species including mammals. However, the mechanism
by which cellular damage leads to EGFR activation within sleep-promoting neurons is not known. As
LIN-3 is the only recognized EGFR ligand in C. elegans, the requirement for LIN-3 in SIS has been
largely assumed rather than carefully examined. Further, attempts to identify a protease that releases
the soluble EGF domain from its membrane-bound proprotein in response to cellular stress have been
unsuccessful. Based on considerable student-gathered data, including findings from unbiased genetic
screens for sleepless mutants, we hypothesize that C. elegans possesses an additional EGFR ligand
that is processed by a stress-responsive metalloprotease, ADM-4, to trigger sleep. We present a
rigorous molecular-genetic research plan involving students that aims to characterize this new EGF
family ligand and its sheddase. These studies are expected to demystify the initiation of stress-induced
sleep, with potential relevance across species, and establish a powerful genetic model for stress-
responsive EGFR activation with relevance to cancer.

Public health relevance
PROJECT NARRATIVE This study will contribute to our fundamental understanding of the molecular basis of sleep need, by investigating the signaling pathways that relay demand for cellular repair to organismal sleep pressure. As this relay involves signaling components that are dysregulated in cancer, these studies are expected to be of broad relevance to human health.